Novel Combination Therapy for Treatment and Prevention of PulmonaryLymphangioleiomyomatosis (LAM) and Tuberous Sclerosis Complex (TSC)

1 ABSTRACT
2 Tuberous sclerosis (TS), also called tuberous sclerosis complex, is a rare, multi-systemic genetic and often life-
3 threatening disease that causes benign tumors to grow in the brain and on other vital organs such as the kidneys,
4 heart, eyes, lungs, and skin. Lymphangioleiomyomatosis (LAM) is a TS-related tumor-like disorder. Both occur
5 as a consequence of an inherited or sporadic mutation in either the TSC1 or TSC2 gene, which function as
6 negative regulators of the mTOR pathway. Uncontrolled mTORC1 activity leads to the neoplastic proliferation of
7 abnormal smooth muscle cells (LAM cells) in the lungs, progressive shortness of breath, recurrent
8 pneumothoraxes, and loss of pulmonary tissue structure and function. In addition, published data suggests that
9 LAM cells may evade immune surveillance by upregulating the surface expression of programmed death-ligand 1
10 (PD-L1). LAM is a rare disease affecting women in childbearing age. The first and only FDA-approved treatment
11 for LAM is the immunosuppressant Rapamycin. It is the current standard-of-care and acts by inhibiting mTORC1.
12 Rapamycin has several clinical disadvantages, including a considerable number of non-responders, severe
13 adverse events due to its immunosuppressive properties and pregnancy category C, limiting its use in women of
14 childbearing age. Thus, there is a high unmet medical need to develop alternative and safer treatment options for
15 LAM and TS. We have identified Anti-PD1 checkpoint blockade as a potential novel therapy for LAM/TS. Using
16 our recently developed immunocompetent mouse model, the Co-PI Prof. Krymskaya was able to show that
17 treatment with an Anti-PD1 antibody significantly improved mouse surival. To advance immunetherapy for LAM,
18 our goal for this grant is the investigation of the mechanistic interplay between Rapamyin and Anti-PD1 antibodies
19 to harness the potential of a combination therapy in vitro and in vivo. Aim 1 will cover a set of in vitro studies,
20 investigating immune-relevant expression patterns and underlying cellular effects on mTOR and related signaling
21 pathways, since the relationship between the former and checkpoint blockade is not fully understood yet. We will
22 use immortalized TSC2-null 101, 102 and TSC2-expressing 103 cells before moving on to our expanded library
23 of primary human LAM-derived AML (LAMD) cells, originating from over 25 LAM patients. Investigating the effect
24 of Rapamycin and mTOR/Akt signalling will increase our understanding of the connection between those pathways
25 and PD-L1 upregulation, before moving on to Aim 2. The in vivo proof of concept will compare preventative and
26 therapeutic co-treatment with Anti-PD1 and Rapamying in an immunocompetent TSC2-null murine model
27 developed at the laboratory of Prof. Krymskaya at the University of Pennsylvania. We will evaluate prevention of
28 TSC2-null lesion growth, immunohistochemical and lung morphology changes and animal survival. This project
29 aims to develop a novel therapy for patients with the devastating diseases of LAM/TS. Based on Pembrolizumab’s
30 favorable safety profile in its approved indications, positive efficacy results in our studies would enable an
31 accelerated clinical development under FDA BPIC act for biologics and orphan disease designation for LAM/TS.
32

Public health relevance
Project Narrative Pulmonary Lymphangioleiomyomatosis (LAM) and Tuberous sclerosis (TS) are multi-system and often life-threatening genetic diseases affecting thousands of people in the United States and approximately 1 million worldwide. We demonstrated that treatment with Anti-PD1 antibodies had positive effects in a murine model of LAM, which may provide a novel therapeutic option for the treatment of LAM and TS. Our proposed in vitro and in vivo research will investigate Anti-PD1 antibodies as a mono- and combination therapy with standard of care in a LAM disease cell culture and mouse model to validate our hypothesis and take the first step to fast-track development for its clinical use in LAM and TS.